Cell junction and nuclear forces as mediators of epithelial cell homeostasis

Epithelial cells, which line both the inside cavities and outside of the body, exist in tissues as monolayers,
multilayers of cells, and three dimensional tube/duct structures. Proper formation and homeostasis of the
epithelium is critical for tissue and organ function; dysregulation of the epithelium is associated with epithelial
barrier loss (including sepsis), defective wound healing, and development and progression of cancer. Strong
cell-cell junctions are critical to the integrity of the epithelium, including cell cohesion, barrier function, and
ability to resist mechanical stress. Loss of junctions is associated with epithelial dysfunction including
inflammatory-induced increases in permeability and epithelial to mesenchymal transition (EMT). Although
formation cell-cell adhesions have been shown to be critical regulators of cell proliferation, migration, and
tissue organization, very little is known how cell-cell junction forces contribute to these processes. In addition,
the nucleus, which is physically connected to the cytoskeleton by the LINC (Linker of Nucleoskeleton and
Cytoskeleton) complex also experiences mechanical force resulting from both actomyosin contractility and
externally applied forces across cell-cell contacts and cell-matrix adhesions. Nuclear forces have been shown
to regulate the cell cycle, nuclear pore complex, and chromatin. Recent work by my group has also shown that
the LINC complex is a critical structure for epithelial homeostasis. This proposal examines the role of force
across proteins in both cell-cell junctions and the nucleus as mediators of epithelial homeostasis. The major
research goals of this R35 MIRA renewal are to 1) examine how mechanical forces regulate epithelial
homeostasis and morphogenesis, 2) identify the role of the LINC complex in epithelial homeostasis and
mesenchymal stem cell differentiation, and 3) investigate how forces across nuclear lamins and nuclear pore
complexes regulate epithelial physiology. Proposed experiments include in vitro models of ductal/glandular
epithelium using FRET-based tension biosensors to directly measure forces across tight junctions, adherens
junctions, and desmosomes, as well as the LINC complex, nuclear pores, and the nuclear lamina. New and
existing technical approaches will be used to modulate these structures, with the objective of identifying both
the upstream regulators of force and the downstream processes regulated by force. Additionally, in vivo
mouse models will be used to assess the role of the LINC complex and desmosomes in 3D epithelial tissue
homeostasis. This comprehensive study of cell adhesion and nuclear forces will greatly advance the
understanding of how epithelial homeostasis is regulated, which is relevant to the processes of wound repair,
inflammation, and epithelial tissue development and organization, as well as epithelial diseases, including
cancer, fibrosis, and chronic inflammation. Furthermore, results from this study concerning the role of forces
on the nuclear lamina and nuclear pore complexes will be relevant to nearly all cell types and tissues.

Public health relevance
In this basic research proposal we will investigate how the mechanical forces across epithelial cell-cell junctions and the nucleus regulate the homeostasis of epithelial cells and tissues, including proliferation, migration, barrier function, and three-dimensional organization. A better understanding of these processes will provide insight into epithelial tissue development, homeostasis, and disease. Results from this study have the potential to identify new therapeutic targets for cancer, fibrosis, wound healing, and chronic inflammation.